Heterotypic amyloid interactions as modulators of selective cellular vulnerability

ABSTRACT
Amyloid aggregates are the defining pathological hallmark of Alzheimer’s Disease (AD), yet the role they play
and the therapeutic effect in targeting these aggregates remains controversial. Little is known about the impact
of the proteome context in which these proteins reside, or what nucleates their aggregation in specific sites in
the brain. Studying the composition of amyloid deposits using proteomic approaches has demonstrated the co-
deposition of many other proteins, however currently there is no straightforward chain-of-events that explains
plaque composition. The predicament in which the field currently subsists critically highlights the lack of suitable
structural-mechanistic models to understand both the causes and consequences of amyloid aggregation in terms
of direct molecular interactions, as well as which specific cellular factors determine pathognomonic disease
initiation.
In this project, the Switch Laboratory in VIB Flanders Institute for Biotechnology will approach the selective
amyloid aggregation of beta amyloid (Aβ) and tau in AD mechanistically and will do a systematic search for
potential interacting partners based on the sequence- and structure-specificity of aggregation. This systematic
and proteome-wide screen is based on the assumption that amyloid aggregation is initiated by the specific
interaction of aggregation-prone regions (APRs) within Aβ and tau with aggregation-prone sequence segments
in other proteins within the background proteome.
They have developed a unique computational pipeline to model heterotypic interactions with sufficient predictive
power to identify amyloid modifiers in cells. The project will investigate the in vivo impact of heterotypic amyloid
interactions in mouse models and for the hits, will analyze in molecular detail how the aggregation of Aβ and tau
is modified by the interactions.
Aim 1 will run an in-silico screen with special emphasis on known factors related to selective vulnerably. The
computational screen will use all-atom modelling of sequence segments with sequence homology to the APRs
of Aβ and tau to identify other brain-expressed proteins that may modify the aggregation of Aβ or tau. Aim 2 will
screen full-length proteins in cellular models to identify candidates that can modify amyloid aggregation of Aβ
and tau in a complex biological context. Aim 3 will identify modifiers that have an effect in vivo by expressing the
most potent modifier proteins in mouse models, to study the impact on aggregation onset and extent of amyloid
pathology of Aβ and tau. For the most promising modifiers identified in Aims 2 and 3, Aim 4 will unravel the
molecular mechanism of selected heterotypic amyloid interactions use state-of-the-art biophysical methods to
elucidate exactly how these interactions change the amyloid formation of Aβ and tau.

Public health relevance
NARRATIVE The aggregation and deposition of Amyloid-beta and tau are crucial pathological hallmarks of Alzheimer’s Disease (AD), but it remains unknown why certain cells and brain regions are vulnerable to their aggregation, and others less. The proposed project from the Switch Laboratory in VIB Flanders Institute for Biotechnology aims to perform a systematic search for potential interacting partners based on the sequence- and structure- specificity of aggregation in a project that starts with a computational search and then proceeds to verify potential interactor proteins in cells, in live animals, and using an extensive array of biophysics assays. This research may lead to a major breakthrough in current treatments of AD by providing a structural model with which the entire set of proteins within brain cells can be screened for potential interactors with the aggregates normally found in AD, providing potential therapeutic value.